Characterizing intact proviral HIV-1 reservoir size and determinants of reservoir dynamics in African populations

Project Summary
Antiretroviral treatment is unable to clear HIV-1 infection because a highly stable latent viral reservoir
persists in the host. Key areas of interest with respect to HIV-1 eradication strategies include latent
reservoir establishment, size and make-up. A considerable amount is now known about these key areas in
subtype B-infected American men, yet there remains limited knowledge in the most affected population,
subtype C-infected South African women, or in African populations in general. Population differences may
exist with respect to reservoir characteristics, and eradication strategies would need to take such
differences into account. Characterization of the HIV-1 reservoir in the African context therefore represents
a much needed area of attention.
This project proposes to firstly address the need for implementation of a high-throughput, accurate reservoir
sizing method in South Africa through optimization of the newly developed intact proviral DNA assay (IPDA)
for subtype C HIV-1. This method will be applied to more than 200 women from KwaZulu Natal. Reservoir
size in these women will be compared to that of individuals from Ugandan and American cohorts using the
same assay to evaulate reservoir differences across populations. This project will also investigate a role for
the viral factors Nef and the long terminal repeat, which are drivers of immune evasion and gene
transcription respectively, in reservoir size and make-up in a subset of these women. Finally, we will explore
the contribution of viral variants from the blood and cervix to the long-lived reservoir in these women using
Bayesian evolutionary analyses.
We hypothesize that Nef-mediated MHC-I downregulation and LTR activity have independent effects on
reservoir size and distribution, and these effects differ according to infecting subtype and study population.
This project will allow for comparison of reservoir size across populations using a standardized assay and
will evaluate determinants of size and kinetics of establishment.

Public health relevance
Project Narrative There is a significant need for large-scale African studies that examine the size and make-up of the latent viral reservoir that exists in HIV-infected individuals on antiretroviral treatment. This project proposes to transfer a newly reported highly accurate reservoir sizing method developed using American populations to measure reservoir size in South African women, and to investigate the role of multiple viral factors in reservoir size and composition. The contribution of viral variants from the blood and cervix to the reservoir will also be explored.